Investigation of factors regulating von Willebrand factor expression

Summary
The overall aim of this project is to characterize the non-coding genomic sequences involved in regulating the
transcriptional activity at the von Willebrand factor locus (VWF). Deficiencies and supranormal levels of VWF
are associated with bleeding and thrombotic disorders, respectively. However, the mechanistic basis for
determining VWF plasma levels, both in healthy and quantitative pathologic state remains poorly understood.
Three specific aims are described in this project. In Aim #1, we will investigate details of the transcriptional
regulation of VWF and FVIII in various subtypes of endothelium. This will involve a combination of
experimental and computational studies including single cell analyses and spatial transcriptomic investigation.
The results of these studies will provide new information concerning the cell types, transcriptomic pathways,
and anatomic niches involved in the expression of these proteins. In Aim #2, we will investigate the non-coding
genomic sequences engaged in the basal transcriptional regulation of VWF. These studies will utilize a range
of orthogonal in-silico and cell-based strategies to evaluate the regulatory potential of non-coding candidate
regions both within and adjacent to the VWF locus. The information derived from these studies will
subsequently be integrated into the analysis of the population cohort studies of subjects with low and high
levels of VWF enrolled in Projects 1 & 2 of this PPG. Lastly, in Aim #3, we will conduct studies to address the
phenomenon of the age-dependent increase in plasma VWF. We have evidence from prior mouse studies that
increased VWF mRNA production contributes significantly to this phenomenon. In Aim #3 we will evaluate
several non-coding sequences for which we have preliminary results indicating biological plausibility for their
causal engagement in age-dependent VWF expression. These studies will utilize in-silico and various cell-
based approaches including the assessment of transcriptional activity in conditions of shear-flow and
inflammation simulating the aging vasculature. Lastly, further studies will be conducted in aging mice to provide
complementary in vivo support for our in vitro findings.